HIGH CARBOHYDRATE AND HIGH FAT DIETS AND WEIGHT LOSS

This study will be conducted in Black women because this group has been historically overlooked by most weight loss studies and because they have a disproportionately high prevalence of obesity. The primary aim of this proposal is to investigate whether a hypocaloric high carbohydrate diet will result in a higher loss of body weight and body fat than a high fat diet of the same energy value while rigorously controlling for confounding variables such as physical activity and dietary compliance.